Arkansas Center for Health Disparities (ARCHD) Bridge Funding

PROJECT SUMMARY/ABSTRACT - OVERALL
Health disparities are a significant problem in Arkansas, arguing for research to eliminate them. The
development and support of researchers and communities who can conduct research to elucidate the
mechanisms underlying these disparities and test the effectiveness of strategies to achieve health equity is
essential. In the proposed bridge funding year, we will continue to complete research in minority health
disparities, promote the training of a diverse research workforce, disseminate research findings, and foster
collaborations and partnerships through the activities of the Arkansas Center for Health Disparities (ARCHD).
The ARCHD builds on 15 years of strong, collaborative work as a Center of Excellence, continuing its thematic
focus on developing multidisciplinary, multilevel research that reduces chronic disease risk factors for
which there are significant health disparities among socially disadvantaged African American
communities, with a goal of improving health and quality of life and ultimately eliminating health
disparities. ARCHD will maintain three core units – an Administrative Core to provide overall coordination and
management of Center activities, including the coordination of common data elements, evaluation, and
methods expertise; an Investigator Development Core, to continue a pilot project program for early stage
investigators and to provide mentorship and guidance; and a Community Engagement and Dissemination
Core, to expand and facilitate equitable, sustainable, collaborative relationships with community and other
stakeholders and to coordinate dissemination of research findings to diverse audience segments. The Center
will continue two full research projects, both using a community health worker model to deliver interventions to
disadvantaged African American populations, i.e., female African American tobacco users in rural communities
and recently incarcerated African Americans at high risk of contracting HIV. We will also continue to foster
additional research addressing minority health disparities, the dissemination of which may inform efforts to
create systematic change in policies, programs, and environments to reduce and eliminate health disparities.

Consistent with the theme of the ARCHD, the long-term goal of this study is to reduce the burden of
multiple tobacco exposures, improve access to preventive care, and reduce the risk for chronic diseases
among socially disadvantaged African American women and children. Cigarette smoking prevalence among
African American Arkansan women is nearly double the overall smoking prevalence for African American
women in the United States and rates are increasing among African American women in AR. Health disparities
are often systematically linked to social disadvantage and socially disadvantaged African American women
and children have poorer access to preventive health care, disproportionately higher rates of secondhand
smoke exposure, and lower exposure to smokefree policies in the home compared to advantaged groups.
There are enormous health care provider and infrastructure deficits in rural distressed counties in the AR Delta
region, yet providers play an important role in motivating women to implement smokefree policies in the home
to protect their children. Community health workers, who are from the community, could have a powerful
influence on womens’ adoption processes by increasing the awareness of the innovation—in this case,
smokefree policies—and persuading them to consider, adopt, and sustain the innovation. Women caregivers
often establish rules for smoking in the home, but the diffusion of evidence-based tobacco control policies in
rural distressed communities has been slow. This mixed-methods study will apply an implementation
framework using the Diffusion of Innovation Theory, Health Belief Model, and Theory of Reasoned Action to
guide the development and implementation of an intervention that aims to increase the adoption and
implementation of comprehensive smokefree policies (ban on cigarettes, cigars, electronic cigarettes, hookah
and safekeeping products from children) in the homes of socially disadvantaged African American women
caregivers aged 18-50 years who live in the AR Delta region. Our transdisciplinary team, the Coalition for a
Tobacco Free Arkansas, Tri-County Rural Health Network, and the University of Arkansas for Medical
Sciences, will implement a small-scale randomized trial that tests the feasibility and compares the efficacy of
the intervention group (community health worker + risk communication materials + brief motivational
counseling + tobacco exposure feedback on the child) to the control group (risk communication materials) on
the primary outcome, implementation of smokefree policy in the home and the secondary outcomes, quitting
and smoking reduction at 3, 6, and 12 months. Our aims are to 1) conduct semi-structured interviews among
African American women to understand multi-level and -domain factors that influence tobacco use and policy
practices; 2) use the interview data to develop, adapt, pilot test the intervention prototypes; and 3) assess the
influence of the intervention on the study’s outcomes.

Public health relevance
PROJECT NARRATIVE Arkansas is among the least healthy states in the nation, with chronic disease prevalence and mortality among the highest of all states, and the state has been identified as having among the greatest minority health disparities in the country. Reducing these disparities and thereby reducing the morbidity and mortality burdens in the state is essential to improving the public health in Arkansas.